Advancing understanding of perinatal binge eating attitudes and behaviors: A longitudinal investigation of the role of ovarian hormone and executive function changes across pregnancy and postpartum

PROJECT SUMMARY/ABSTRACT
Approximately 40% of community samples report binge eating attitudes/behaviors (BE) during pregnancy – far
exceeding pre-pregnancy and postpartum estimates and nearly triple the rate observed among non-perinatal
community samples. Importantly, BE, which comprise symptoms of binge eating disorder that may not
constitute a full threshold diagnosis, are associated with adverse short- and long-term mental and physical
health outcomes that increase cardiovascular disease risk for birthing individuals and their offspring. Despite
their high prevalence and link to deleterious intergenerational health consequences, efforts to treat and prevent
perinatal BE are lacking due to limited knowledge of underlying target mechanisms. The goal of the applicant’s
proposed research is to advance understanding of whether and how changes in ovarian hormones and
executive functioning (EF), two factors implicated in the development and maintenance of BE among non-
perinatal individuals, contribute to changes in BE across the perinatal period. Based on findings from research
with non-perinatal samples, perinatal-related increases in progesterone and decreases in EF are hypothesized
to predict increases in perinatal BE, whereas perinatal-related increases in estradiol are hypothesized to
predict decreases in perinatal BE. To test these hypotheses, and potentially identify malleable risk and
protective factors crucial to intervention development, the proposed research will integrate two longitudinal
studies, harnessing existing data from >300 participants spanning five timepoints across the perinatal period,
and employ structural equation models (SEM) that can examine complex patterns of change in multiple
variables over time and how these changes influence each other. The Specific Aims of the proposed research
are to: (1) investigate (a) progesterone and (b) estradiol as predictors of perinatal BE; (2) investigate EF as a
predictor of perinatal BE; and (3) explore the relative contribution of ovarian hormones and EF to perinatal BE.
To accomplish these aims, the applicant will complete a comprehensive, personalized training plan comprised
of journal article readings, seminars/workshops, scientific conferences, coursework, clinical work, and tailored
mentoring from a committed team of researchers with expertise directly relevant to the proposed research. The
Training Goals, which build upon the applicant’s prior research experiences and training, will focus on
expanding knowledge and/or skills in: (1) perinatal disordered eating and mental health; (2) ovarian hormones
and disordered eating; (3) the multidimensionality of EF and scoring/analysis of data from behavioral task
measures of EF; and (4) longitudinal SEM procedures. Complemented by the dedicated research and training
environment at the University of Pittsburgh, this F31 fellowship will accelerate the applicant’s trajectory toward
becoming an independent researcher focused on identifying and modifying target mechanisms related to
perinatal BE, the most prevalent form of disordered eating among perinatal individuals, to promote the mental
and physical health of this vulnerable population.

Public health relevance
PROJECT NARRATIVE Binge eating attitudes and behaviors during pregnancy and the postpartum period are extremely common and associated with adverse health outcomes for birthing individuals and their offspring. This research will further knowledge of whether and how two biopsychological mechanisms, ovarian hormones and executive functioning, contribute to binge eating attitudes and behaviors across pregnancy and the postpartum period. This research therefore has the potential to identify malleable risk and protective factors crucial to developing interventions that effectively reduce and prevent binge eating within the unique and high-risk contexts of pregnancy and postpartum and, ultimately, promote intergenerational health.